Recurrence markers, cognitive burden and neurobiological homeostasis in latelife depression (REMBRANDT) - Supplement

This proposed administrative supplement will explore the association of late-life depression with cognitive
decline and cognitive diagnoses. We propose to add to the extensive clinical and neuropsychological measures
used in R01 MH121619 measures of pathophysiology [plasma biomarkers of ADRD including plasma amyloid-b
peptides 42/40, plasma phosphorylated tau 181 (p-tau181), neurofilament light chain (NFL), glial fibrillary acidic
protein (GFAP)], molecular senescence and chronic inflammatory burden [senescence-associated secretory
phenotype proteomic panel (SASP)], as well as cognitive classification and diagnosis of every participant. In
conjunction with the data already collected in the parent R01, the data obtained through this supplement will be
used for a future R01 designed: 1) to confirm the cumulative effect of LLD episodes on ADRD risk and the
moderating role of molecular senescence and chronic inflammatory burden; and 2) test longitudinally the effect
of antidepressant treatment on ADRD biomarkers, molecular senescence, inflammatory markers, and cognitive
decline including cognitive diagnoses (e.g., MCI, dementia). This proposal is responsive to NOT-AG-22-025 as:
1) it is within the scope of the research already supported; 2) it is focused on AD and AD related dementias
(ADRD) by adding AD plasma biomarkers to the existing condition already studied (LLD); 3) it will stimulate
additional activity leading to progress on ADRD by drawing attention toward a common and modifiable risk
factor (LLD) and by laying the groundwork for future exploration of mechanisms connecting LLD with
inflammation and risk of AD/ADRD. The 1-year design is feasible given our successful recruitment in the parent
R01, recruitment which allows us to identify a significant number of older participants with current and remitted
LLD. Additionally, the measures proposed in this supplement have already been developed and tested
extensively by collaborators and co-investigators on this proposal (Drs. Thomas Karikari and Breno Diniz).
Finally, co-investigator Dr. Butters has substantial experience leading and conducting cognitive diagnostic
adjudications based on the University of Pittsburgh ADRC procedures.
1

Public health relevance
PROJECT NARRATIVE Depression is a recurrent illness and even with successful antidepressant treatment, older adults with late-life depression are at high risk of recurrence and have a high risk of cognitive impairment. This proposed administrative supplement will explore the association of late-life depression (LLD) with biological evidence of Alzheimer's Disease and Related Dementias as well as systemic markers of inflammation/senescence.